Training Program in Cancer Biology and Therapeutics

ABSTRACT
The Massachusetts General Hospital (MGH) Cancer Center proposes to renew its T32 Training Program in
Cancer Biology and Therapeutics, supporting mentorship of seven physician scientists (MDs and MD/PhDs)
for careers in cancer research. With a 20-year history, the program has enrolled multi-disciplinary trainees who
have completed clinical fellowships in medical, surgical, pediatric, or radiation oncology, and supported their
training in laboratory-based or clinical cancer research. The program aims to prepare the next generation of
physician scientists for academic careers in oncology, strengthening fundamental research in cancer biology
and its translation into clinical therapeutics. Program co-Directors are Dr. Daniel Haber, an accomplished
laboratory-based cancer genetics investigator and Dr. Alice Shaw, a leading clinical researcher in thoracic
oncology. They will oversee all administrative aspects of the program, with Dr. Haber overseeing the mentoring
of lab-based trainees and Dr. Shaw overseeing the mentoring of clinical research trainees. An Internal Advisory
Committee (IAC) will participate in the competitive selection of trainees and in the selection of faculty for the
roster of mentors; an External Advisory Committee (EAC) will convene annually to evaluate the strategic direction
and success of the program. Mentors are drawn from multiple disciplines and departments, primarily from MGH,
and including selected faculty from neighboring MIT and other Harvard institutions. Special emphasis has now
been placed on recruiting new mentors in the emerging field of cancer immunology. Trainees are selected across
multiple clinical oncology specialities, from programs that are among the most competitive in their respective
fields, with a commitment to enhancing diversity. In addition to facilitating the selection of an appropriate research
mentor, the T32 program provides both mandatory and optional courses, as well as a broad range of educational
experiences. The formal educational offerings have been strengthened with required didactic courses in
biostatistics/computational biology and in the ethical conduct of research, along with specialized optional
courses. Trainees will now present their work at an annual retreat. PDs and the IAC will be involved in the
evaluation of their progress. Success is measured by trainees' academic productivity during and after their T32
support, as well as by their self-reported learning experience. In summary, the MGH T32 Training Program in
Cancer Biology and Therapeutics has a long track record of success in providing a rigorous and comprehensive
scientific foundation to outstanding physician investigator trainees who aim to establish successful academic
research careers in oncology. The program's strength in multi-disciplinary training and integrated laboratory and
clinical investigation has been further improved with an enhanced focus and dedicated educational resources,
as recommended by the reviewers. With continued funding from NIH, this training program will build on its
longstanding success in training future leaders in academic oncology and help advance the field of cancer
research globally.

Public health relevance
Narrative We are witnessing an exceptional time in oncology, where fundamental discoveries in our understanding of cancer biology are leading to revolutionary changes in the treatment of patients with cancer, including genotype-directed targeted therapies, antibody and cell-based immunotherapies, and the application of molecular liquid biopsies to enable the earlier detection of cancer followed by potentially curative interventions. The MGH T32 physician scientist Training Program in Cancer Biology and Therapeutics selects trainees from some of the most competitive clinical programs in medical, surgical, radiation, and pediatric oncology, offering them advanced training in either laboratory or clinical cancer research, with highly accomplished mentors drawn from a multidisciplinary faculty at MGH, as well as our partnering institutions at Harvard and MIT. Over the past 20 years, graduates of the MGH T32 grant have made and will continue to make major contributions to the field of cancer research, and as members of the faculty at our own institution and others in the US, they are poised to emerge as the next generation of physician leaders in oncology, contributing to the critical integration of scientific and clinical innovation in cancer.